X RAY DIFFRACTION MEASUREMENTS AT ARGONNE SYNCHROTRON

DESCRIPTION: This core X-ray facility provides for the collection and processing of the diffraction data for this program project at the Advanced Photon Source at Argonne National Laboratory. The PI is on site, which will allow beam time to be scheduled in a highly efficient way. Approximately ten days per year will be made available for data collection at one of two beamlines. The beamlines are specialized to collect efficiently multi-wavelength anomalous X-ray data.